MCW NCTN Lead Academic Participating Site Administrative Supplement

PROJECT SUMMARY
An effective National Cancer Clinical Trials Network (NCTN) must be led by centers with commitment to, and
expertise in, the collaborative clinical trials process. The Medical College of Wisconsin (MCW) has a 45-year
tradition of such commitment as demonstrated by scientific leadership in the development and conduct of
clinical trials in association with NRG Oncology, Alliance for Clinical Trials in Oncology, ECOG-ACRIN, and
SWOG, in addition to leadership and substantial accrual to other National Cancer Institute (NCI)-funded trials
networks. In the past 5 years, the Froedtert and MCW Cancer Center (FMCWCC) has gone
through transformative growth and is well-positioned to exert sustained meaningful influence as a Lead
Academic Participating Site (LAPS). FMCWCC has a leadership team with diverse experience, a proven
track record, and an effective infrastructure that will continue to provide scientific leadership in the
development of trials, contribute to timely accrual and completion of trials, and mentor the next generation of
investigators. FMCWCC will support the mission and the operation of the NCTN by: 1) providing leadership
in developing important and successful multicenter trials that address critical issues in cancer diagnosis
and treatment utilizing MCW expertise in pre-clinical, translational, and early and advanced phase clinical trial
research; 2) providing robust accrual to NCTN trials with wide participation by all MCW cancer
disciplines; and 3) developing the next generation of NCTN clinical scientists through mentoring programs
and advanced methods training. MCW has played a scientific leadership role in national adult clinical trials
programs for many decades and has made substantial recent investments in recruitment and infrastructure
to vigorously grow its clinical trial program. This comes with an explicit commitment to grow NCTN
activities by: (i) empowering the NCTN leadership in our Cancer Center infrastructure; (ii) engaging
faculty with extensive expertise in both the cooperative groups and other non-profit trials networks to
develop, activate and accrue to NCTN trials; (iii) centralizing and expanding clinical research support
activities to further increase capacity, efficiency and accrual; and (iv) mentoring the next generation of
investigators.

Public health relevance
PROJECT NARRATIVE The Medical College of Wisconsin has a 45-year tradition of commitment and expertise in the collaborative clinical trials process as demonstrated by scientific leadership in development and conduct of clinical trials in association with NRG Oncology, Alliance for Clinical Trials in Oncology, ECOG-ACRIN, and SWOG.